Point-of-care Testing (POCT) Tool Development for Critical Oxytocin Measurement

PROJECT SUMMARY/ABSTRACT
Point-of-care Testing (POCT) Tool Development for Critical Oxytocin Measurement
Oxytocin, a neuropeptide hormone, is best known for its role in the facilitation of childbirth through induction of
myometrial smooth muscle contractions. Exogenous administration of oxytocin is critical in child birth for
induction and augmentation of labor. Oxytocin is also administered to manage postpartum uterine atony and
hemorrhage. Oxytocin levels also have great significance during the perinatal period as a potential biomarker
for prediction of type of labor. Increased levels of circulating peripheral oxytocin levels are also linked to
postpartum breast milk production, as well as decrease in frequency of migraine headaches over the course of
pregnancy.
There is an increased interest in accurate determination of oxytocin levels in the body; however, research in
this area has unfortunately been limited by lack of noninvasive methods, especially considering the
involvement of vulnerable patient populations. Therefore, it would be extremely valuable to provide researchers
and medical professionals with a simple and practical point-of-care Testing (POCT) instrument that would
accurately determine the peripheral levels of oxytocin. Currently, oxytocin measurements are made using
commercially available immunoassays; however, these methods are not sufficiently specific and they also
require skilled personnel and laborious sample preparation protocols that result in long turn-around-times
(hours to days). The instrumentation is expensive as well and does not lend itself to desktop or portable needs.
To the best of our knowledge, there is no currently available instrument that is capable of POC detection of
oxytocin. Giner, Inc. will develop an electrochemical assay and validate a POC instrument for highly
sensitive and near-real-time perinatal monitoring of oxytocin. Enabling measurement of oxytocin with a
Limit of Detection (LOD) of 1 pg/mL, our novel electrochemical assay establishes fundamental development on
such a POC device with high sensitivity and specificity. The Phase I program will improve and validate the
current assay and build a pre-prototype that features a disposable cartridge coupled to a handheld reader. The
entire assaying time will be less than 2 minutes. The Phase I program will build on successful preliminary
results and Giner’s prior experience in biosensors to validate an electrochemical oxytocin monitor using both
saliva, and blood samples. These samples will be collected and quantified by BioIVT and the results obtained
from Giner’s assay will be benchmarked against the standard LC-MS/MS method.

Public health relevance
PROJECT NARRATIVE The overall goal of this program is the development of an electrochemical assay and validation of a point-of-care instrument for monitoring oxytocin in whole blood as well as minimally invasive biological samples such as saliva. Oxytocin is a hormone that is known for its key role to facilitate the birth process and its exogenous administration is critical in a clinical setting for induction and augmentation of labor as well as management of postpartum uterine hemorrhage. Therefore, an oxytocin sensor would be a valuable tool for researchers and medical professionals to study drug pharmacokinetics and enable adjustment of the dose of oxytocin administered.